Impact of paternal care on stress-coping behaviors and neuropeptide systems

Project Summary/Abstract
Heightened sensitivity to stress can lead to maladaptive coping behaviors, such as social withdrawal and
aggression. Children that experience early-life adversity (ELA) have an increased risk of developing similar
difficulties, particularly after experiencing subsequent stressful events in later life. Parental care, and paternal
care in particular, can have protective effects on the development of social behavior and well-being. Yet, the
impact of paternal care and the neuroendocrine factors that are involved in responsiveness to later life stress in
offspring are vastly understudied, and an animal model for mammalian biparental care and stress
responsiveness is greatly needed. Further, oxytocin (OT) and vasopressin (VP) are essential neuropeptides that
modulate social behaviors but epigenetic modifications of their receptor genes in response to ELA have not been
well characterized. I will develop a two-hit model of ELA and adolescent stress by using the bi-parental prairie
vole (Microtus ochrogaster) to assess how paternal deprivation during a specific pre-weaning sensitive window
biases sensitivity to adolescent chronic social defeat stress through OT- and VP-related changes in the lateral
septum and neural activity therein. The effects of paternal deprivation from birth in prairie vole offspring have
been reported to induce deficits in pair bonding, and region-specific and sex-specific modifications in OT and VP
receptor expression. Yet there is a research gap in examining the consequences of disrupting direct paternal
care or breaking father-offspring bonds, the interaction of paternal deprivation with chronic social defeat stress,
and its collective impact on genetic, epigenetic, transcriptomic mechanisms the mediate offspring social behavior
and brain development. This project will integrate multiple levels of analysis (behavioral, epigenetic, cell-specific
gene and protein profiling, and neuronal function) to understand the mechanisms in the lateral septum through
which paternal deprivation can mitigate reactivity to stressors in adolescence.

Public health relevance
Project Narrative Neglect, abandonment, abuse, and other forms of early life adversity significantly increase risk for psychiatric disorders, such as depression, by shifting developmental brain trajectories and sensitizing individuals to subsequent stress. This proposal tests the hypothesis that paternal deprivation alters the lateral septum to respond to social stress experienced later in life via neural, epigenetic, and transcriptomic mechanisms that act on the function of the oxytocin and vasopressin systems. This work will contribute to a novel understanding of stress susceptibility and can provide insight to better inform new therapeutic strategies to understand the developmental differences in how sociality is altered by early life adversity.